Systemic immunoregulatory consequences of bacterial translocation during health and disease

Autoimmune hepatitis (AIH) is a chronic, progressive, auto-inflammatory liver disorder that often becomes
refractory to immunosuppressants-the sole therapeutic option for AIH patients. Hepatic inflammation, which sets
the stage for overt AIH, is considered the main driver of hepatic tissue damage and fibrosis. While reversible, in
the absence of treatment AIH progresses to cirrhosis and end stage liver disease, requiring liver transplantation
in around 10% of cases. Its exact trigger and the underlying mechanisms by which AIH develops are poorly
understood, although genetic and environmental factors play an important role. The local liver microbiome has
been identified as one critical environmental factor that modulates hepatic pathology. The expansion of
commensal bacteria such as Lactobacilli spp. within the liver is associated with an increased severity of
experimental liver pathology, and Lactobacilli spp. are enriched in livers of AIH patients. Our lab recently
published that Lactobacillus reuteri (L. reuteri) translocates to internal tissues and thereby drives systemic
inflammation in mice that lack the epigenetic regulator Tet methylcytosine dioxygenase 2 (Tet2) in hematopoietic
cells (Tet2VAV mice). We recently found that such mice have AIH and are a model system to study this disease,
supported by epidemiological evidence that TET2 deficient individuals display cardinal features of liver disease.
The pathogenetic mechanisms underlying AIH, and in particular how the liver microbiome may drive it, are
unclear. Interferon- γ (IFN-γ) producing TCR CD8 T cells (Tc1 cells) have been identified to play an essential
role in AIH. Missing is an understanding of the key signals from the liver microbiota and how they are linked to
the induction of such pathogenic cells. Intriguingly, L. reuteri efficiently catabolizes dietary tryptophan (Trp) to
the aryl hydrocarbon receptor (AhR) agonist indole-3-carbinol (I3C). In a lupus model, AhR ligands derived from
E. gallinarum promoted Th17-driven autoimmunity. Here, based on our new data and this context from the
literature, we propose a model and testable hypothesis explaining how L. reuteri promotes AIH. We will test our
central hypothesis that L. reuteri promotes hepatic Tc1 cell immunity by releasing I3C and/or by fueling L. reuteri-
specific Tc1 cells in two independent models of AIH (Tet2VAV mice and Concanavalin A-mediated hepatitis).
Furthermore, we posit that therapeutic approaches that suppress AhR signaling protect from L. reuteri-triggered
Tc1 cell mediated AIH-like pathology. We will investigate this hypothesis in three specific aims. In Aim 1 we will
determine whether L. reuteri derived I3C acts directly on CD8 T cells via AhR, which promotes Tc1 cell effector
function that drives AIH-like pathology. In Aim 2 we will define whether L. reuteri-specific CD8 T cells drive AIH-
like disease. In Aim 3 we will define therapeutic approaches targeting AhR signaling within CD8 T cells (dietary
Trp, AhR blockade) in protecting from AIH-like pathology. These aims will lead to a better understanding of the
pathophysiology of AIH and assess rationale therapeutic interventions for patients with AIH.

Public health relevance
Public Health Relevance This proposal aims to dissect the underlying mechanisms of how the host (Tc1-cells) and the liver microbiota (L. reuteri) affects AIH-like pathology and will assess the efficacy of therapeutic interventions (Trp diet, blocking AhR) to alleviate AIH pathology. The proposal will have a significant positive impact on human health because it will advance our understanding of the pathophysiology of AIH and assess rational therapeutic interventions for patients with AIH. Thus, this work will directly support the NIDDK mission of developing fundamental knowledge that will help reduce the burden of human disease, and improve the health of patients with autoimmune hepatitis.